Hispanic Alliance for Clinical and Translational Research (Alliance)

Hispanic Alliance for Clinical & Translational Research (Alliance)
ABSTRACT
Improving health care for the medically underserved, including our Hispanic population, afflicted
by prevalent diseases, such as cancer, cardio-metabolic and infectious diseases, remains a major
challenge. The current application is to support the development of Hispanic Alliance for Clinical
& Translational Research in Puerto Rico (Alliance), which aims to build on the existing
infrastructure of the Puerto Rico Clinical and Translational Research Consortium (PR-CTRC an
RCMI-CTR) and the unique expertise on emerging infectious diseases and strategic positioning
for the study of disaster-related conditions and their impact on Health. The Alliance expands the
scope of our successful 8-year partnership by leveraging intellectual and physical resources of
the three major academic health sciences centers on the Island: the University of Puerto Rico
Medical Sciences Campus, the Universidad Central del Caribe, and the Ponce Medical School
Foundation and key-collaborating institutions to support an integrated, island-wide program
dedicated to the conduct clinical and translational research. The Alliance is founded on our
hypothesis that research-driven improvements in health outcomes requires an integrated network
of key stakeholders representing academia, government, community-based organizations and
health care delivery systems working together in an interdisciplinary, multi-sectorial clinical-
translational research model. The objective of the Alliance is to serve as the catalytic center to
enhance the competitiveness of investigators to conduct research and obtain additional funding
for clinical and translational research addressing highly prevalent diseases and those that affect
the medically underserved in PR. The long-term goal of the Alliance is to transform clinical and
translational research in Hispanic populations in the mainland and in Puerto Rico by promoting
inter-disciplinary collaboration and leverage of resources to address diseases affecting Hispanic
communities.

Public health relevance
Project Narrative The Hispanic Alliance for Clinical and Translational Research is relevant to public health because it will help advance our fundamental knowledge of ethnic-specific factors that could explain the disproportionate burden of certain diseases, and the limited or lack of effective treatment for this ethnic subgroup, which is increasingly represented in the US mainland population. The long-term goal of the Alliance is to transform clinical and translational research in Hispanic populations in the mainland and in Puerto Rico by promoting inter-disciplinary collaboration and leverage of resources to address diseases affecting Hispanic communities. The project is relevant to the NIH mission because it will contribute with training the next generation of scientists, develop research capacities, and will enhance the diversity of the scientific workforce.